Exonuclease Based Microsatellite Sequencing

Project Summary
Electronic BioSciences (EBS) will investigate and develop methodologies to sequence microsatellite regions
within the human genome to enable cancer genotyping via a true single-molecule, ultra-high-accuracy approach.
Microsatellites are simple/short repeats (1-10 nucleotides in length) that occur in tandem 5-50 times and are
among the most variable types of DNA sequence in the genome. Mutations to these microsatellite regions, or
what is referred to as microsatellite instability (MSI), includes expansion or contraction of the repeat number,
single nucleotide polymorphisms (SNPs), and/or insertions or deletions (indels), which have been documented
with all current types of cancer. Unfortunately, current sequencing technologies, including both next generation
sequencing (NGS) and third generation sequencing (TGS), are not capable of sequencing microsatellites and
MSI with any sort of clinically relevant accuracy or precision due to limitations with the methodology utilized,
which has significantly hindered the understanding of these types of sequences. During this Phase I SBIR
program, EBS will focus on developing a new platform and sequencing approach specifically aimed at
microsatellites. The investigations performed during this program will enable new approaches to probe
microsatellites, MSI and the human genome in general, directly improving basic cancer research and ultimately
enabling vastly improved clinical diagnostics and/or prognostics technologies.

Public health relevance
Project Narrative This program is aimed at developing a direct, electrical, nanopore-based, true single-molecule, ultra-high- accuracy sequencing technology/methodology, specifically for microsatellite sequencing and microsatellite instability assessments to enable cancer research, diagnostics, prognostics, and therapy determinations. As a specific example, the third most common cancer in men and women in the US currently is colorectal cancer, which results from quite variable genetic differences that include the presence or absence of microsatellite instability; the technology developed during this program will become the go-to diagnostic tool when making colorectal cancer treatment decisions. Ultimately, by developing technology that far outpaces current state-of- the-art, we will enable a vastly improved understanding of cancer-driving mutations and general knowledge of the genome such that human health and patient care will be greatly improved.